Emerge: Emerging Diseases Epidemiology Research Training

Program Director/Principal Investigator (Last, First, Middle): LESCANO, Andres G.
The last five years have been a volatile period in South America with the massive emergence of Zika and its
congenital syndrome, the Brazil yellow fever outbreak that threatened to exhaust the regional vaccine
stockpile, the Venezuelan crisis that led to significant migration and measles outbreaks, and an unprecedented
surge in malaria cases that crippled the progress achieved in malaria control. Indeed, Peru was affected by
these challenges and suffered its largest dengue outbreak on record with nearly 70,000 cases and 89 deaths
after the sudden 2017 Coastal El Niño event. Therefore, to strengthen early detection and effective responses
to these epidemic threats, we will provide advanced Master’s and doctoral training opportunities to Ministry of
Health personnel. This will create an Epidemiology Master’s program in the Amazon Basin and strengthen our
satellite research unit on the northern coast of Peru and secure the long-term sustainability of our new
epidemiology doctorate. These strategies will result in better-trained epidemiologists in larger numbers, and
present in the critical, high-risk areas where they are needed the most. Our objective will be to consolidate and
secure a self-sustainable and cost-effective epidemiology doctorate in Peru by replicating the successful model
of our Master’s program and creating a continuous pipeline of emerging diseases epidemiologists to respond
to outbreaks and prevention and control efforts. The expected outcomes for the next five years are: 1) 20 PhDs
graduates from the Peru program and 12 more under training with a streamlined curricula to improve
graduation and research outcomes, 2) 30 graduates from a new, decentralized Epidemiology Master’s program
in Iquitos and 90 additional graduates from our Lima Master’s, ~15% conducting research in emerging
diseases and ~20% from the public sector, 3) One doctoral and five Master’s graduates of the Peruvian CDC
trained jointly with the US CDC, 4) Six highly-selected Peruvian doctorates trained in world-class programs
abroad, four reinserted in Peru in productive research careers, 5) A large pipeline of young professionals
trained and engaged in emerging diseases research via on-site internships (30) and short courses (150).
Experienced research leaders in world-class institutions such as Cayetano, San Marcos, Minas Gerais and
Johns Hopkins universities will partner with Peru and US CDC supported by a broad network of 30 local and
foreign organizations working in Peru. The partners of this program provide a unique, rich and nurturing
research environment with extensive multi-year grant funding from the NIH and other sources that promotes
innovation and addresses hypothesis of public health and scientific significance, particularly for arbovirosis,
antimicrobial resistance, respiratory infections and zoonotic diseases. Our track record demonstrates proof of
concept for the proposed goals after creating an Epidemiology Master’s and Doctorate in Peru, graduating over
200 Master’s students and sponsoring doctoral training for 16 Peruvian scientists at prestigious US and UK
universities. Almost 15% of our Master’s students have already moved into PhD training, and our first cohort
alone has published >200 papers after graduating, a four-fold increase year compared to prior coursework.
More than half of our doctoral trainees abroad have graduated and started productive scientific careers, and
overall, they have published an average of 11 manuscripts each. Current and future trainees are likely to be
even more productive due to enhanced research opportunities, improved coursework and added mentoring.
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): LESCANO, Andres G. Emerging infections continue to be primary concerns in Peru, South America and the world. Zika erupted in the Americas after quietly circulating in Brazil for nearly two years with a catastrophic and yet unexplained impact on microcephaly and the overall Zika congenital syndrome. The Peruvian north coast of Peru recently suffered its largest dengue outbreak on record after the 2017 Coastal El Niño event appeared without warning, leading to nearly 70,000 cases and 89 recorded deaths. Antimicrobial resistance continues to advance worldwide despite major efforts to promote the rational use of antibiotics while Chapare arenavirus re-emerged in neighboring Bolivia just a few weeks ago. Early detection and effective response to future outbreaks of emerging diseases will required better-trained epidemiologists, in larger numbers, and present in high-risk areas. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page